Dissemination and Implementation for Community Engagement

PROJECT SUMMARY: Dissemination, Implementation, and Community Engagement (DICE) Core
The Dissemination, Implementation, and Community Engagement (DICE) Core recognizes the transformative
potential of well-equipped and diverse teams of scholars, scientists, and clinicians collaborating with patients,
advocates, and communities to drive meaningful and sustained progress in addressing rheumatic and
musculoskeletal disease (RMDs), both in the Deep South and nationally. Led by a strong multi-disciplinary
team with expertise in D&I science, community engagement, research recruitment, virtual/digital, and other
novel strategies, the DICE Core will endeavor to make notable strides towards realizing health equity and
enhancing health outcomes for underrepresented racial/ethnic groups and rural populations by pursuing the
following aims: Aim 1: To Facilitate the Recruitment of Diverse People Living with RMDs for BIGDATA
Research Projects. The DICE Core will aid in the adoption and implementation of evidence-based innovative
strategies for engaging underrepresented race/ethnic and rural populations, ensuring their meaningful
participation in RMD research studies. Via hybrid engagement methods, including online communities and
registries, social media campaigns, and direct-to-patient recruitment approaches, DICE will promote inclusivity
to reach these underrepresented groups. Aim 2. To Provide Comprehensive and Innovative Resources to
the BIGDATA Research Community in Dissemination and Implementation (D&I) Science. We will offer
comprehensive consultation and support to RMD researchers enabling them to effectively test interventions to
implement, de-implement, and disseminate evidence-based interventions to improve outcomes for people
living with RMD. Consultations will build on expertise in patient D&I theory, patient navigation, and training/
enrichment. These offerings will equip researchers with the knowledge and skills necessary to translate RMD
research discoveries into practice. Aim 3. To Engage Communities to Promote Equity in Recruitment,
Dissemination, Implementation and in other BIGDATA Research. In this cross-cutting aim, the DICE Core
will function as a conduit for enabling bidirectional communication between RMD researchers and RMD
communities by leveraging the collaboration of an overarching Patient Advisory Committee (PAC). In its
entirety, the DICE Core will assume a pivotal role in equipping investigators aligned to NIAMS-mission and the
BIGDATA subtheme of health equity and community engagement with the skills, assets, and virtual
mechanisms to propagate research discoveries effectively as well as amplify the involvement and enlistment of
historically marginalized groups. As we pursue the aims outlined by the DICE Core, we are dedicated to
fostering equity, addressing health disparities, being culturally sensitive, and responsive to the unique needs of
underrepresented populations living with RMD. We aim to bridge the gap between research and practice, to
improve patient outcomes, and to contribute to the broader goal of achieving health equity in RMD research.